Directed in vivo assembly of a robust biopolymer particle-based multistage malaria vaccine

PROJECT SUMMARY
The long-term goal of this proposal is to utilize a biopolymer particle-based vaccine platform technology to
develop a safe, effective multistage malaria vaccine that is ambient-temperature stable and can be cost-
effectively mass produced to protect the world against malaria caused by the parasite Plasmodium falciparum.
The objective of this proposal is to apply our innovative vaccine technology that is based on antigen-coated
biopolymer particles (~300 nm) assembled inside bacterial cell factories for design of multistage malaria vaccine
candidates preventing malaria in a rodent model. Safe and effective biopolymer particle vaccine candidates
inducing long-lasting immunity had been developed against eight different infectious diseases. The central
hypothesis is that biopolymer particles can be designed to simultaneously display epitopes or antigen
subdomains of various stage-specific malaria antigens selected to induce broad immune responses to target the
pre-erythrocytic-, blood- and sexual-stage of the parasite. The rationale underlying this proposal is that antigen-
specific antibody and CD8+ T cell responses were shown to inhibit the individual stages of the parasite, and
hence a combination of antigens/epitopes biologically assembled into a biopolymer particle could simultaneously
induce immune responses to block all life cycle stages. Multiple antigens/epitopes had been displayed on
biopolymer particles inducing specific antibody and T cell responses that mediated protective immunity. The
central hypothesis will be tested by pursuing two specific aims: 1) Design and manufacture biopolymer particle-
based malaria vaccine candidates and 2) Evaluate biopolymer particle-based multistage malaria vaccine
candidates. We will pursue these aims by designing and manufacturing biopolymer particles that are densely
coated with selected epitopes and antigen subdomains from vaccine candidate antigens representing the pre-
erythrocytic-, blood- and sexual-stage. Safety and induction of functional inhibitory antibodies against the various
life cycle stages of the parasite will be tested in rats. The ability to induce protective immunity will be evaluated
in the mouse model of malaria infection using transgenic Plasmodium berghei. The proposed research is
significant, because it will determine which biopolymer particle design features are required to induce desirable
immune responses. It will generate foundational resources to advance rational design of vaccines that can be
used by other researchers in the quest of providing solutions for unmet needs in vaccine development. The
proximate expected outcome of this work is an understanding on how biopolymer particle vaccine designs
correlate with cell-mediated and humoral immune responses that mediate protective immunity. The results will
have an important positive impact on providing insight into immune mechanisms correlated with protective
immunity, hence enabling development of an innovative multistage particulate malaria vaccine.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it will utilize our innovative vaccine platform technology to develop a safe, ambient-temperature stable and effective vaccine that can be cost-effectively mass produced to protect the world against malaria. Understanding the requirements for design of a multistage malaria vaccine, which immune responses correlate with protective immunity, will not only be foundational for development of an effective malaria vaccine but will also be groundbreaking for development of vaccines against other infectious diseases. Thus, this proposal is relevant to the part of NIH’s mission that pertains to fostering fundamental creative discoveries and innovative research strategies as a basis for ultimately protecting health.